Personalized Digital Twin for Precise Lung Stereotactic Body Radiation Therapy (SBRT)

According to NOT-CA-24-015, the parent abstract is at the beginning of the research strategy:
“The Research Strategy section should include a summary or abstract of the funded parent award.”

Public health relevance
According to NOT-CA-24-015, a project narrative is not applicable.